Brain Networks Supporting Oral and Pharyngeal Swallow Function after Stroke

PROJECT SUMMARY
Swallowing impairment, dysphagia, is common after stroke and can have serious consequences, leading to
morbidity and reduced quality of life. Despite the significance of dysphagia, we lack fundamental knowledge
regarding the neuroanatomical mechanisms underlying oral and pharyngeal dysphagia to allow us to
accurately predict which patients will 1) spontaneously recover swallow function, 2) need treatment to recover
function, or 3) have limited potential for recovery leaving clinicians making “best guesses” for prognosis guided
decisions such as feeding tube placement and treatment. Such knowledge is critical to improving patient care
and outcomes. It will ultimately lead to being able to prescribe swallowing treatment targeting precise brain
network elements for optimal recovery. Current reasons for our limited understanding of the neural control of
swallowing are three-fold. Most prior research has 1) used approaches to measure dysphagia that cannot
quantify oral and pharyngeal swallow physiology, 2) neglected the simultaneous and concerted contribution of
connected brain areas to swallowing, and 3) drawn inferences from small patient samples recruited from a
single institution. Thus, we propose a mechanistic study to identify and assess the importance and
generalizability of brain networks in oral and pharyngeal swallow impairments in a large cohort of patients. To
overcome limitations from prior studies, we propose to use validated and standardized measures derived from
the Modified Barium Swallow Study, use modern lesion-based symptom mapping analyses to identify a
network of regions and connections (the circuitry) that collectively contribute to swallowing physiology, and
recruit from two major stroke centers in the southern U.S. with a recruitment goal of N=400 individuals. Further,
we will assess the impact of stroke damage on brain circuitries and the impact of age-related neuroanatomical
changes, i.e., white matter hyperintensities. We hypothesize that both stroke lesions and white matter
hyperintensities damage brain networks and contribute to the severity of oral and pharyngeal dysphagia after
stroke. Our study has three aims: 1) to determine the neuronal circuitry supporting the oral phase of swallowing
after stroke, 2) to determine the neuronal circuitry supporting the pharyngeal phase of swallowing after stroke,
and 3) to determine the additional impact of disconnections caused by white matter hyperintensities on the
neuronal circuitry supporting oral and pharyngeal swallowing after stroke. From our study, we expect to identify
a set of brain regions and connections that form a brain network supporting oral swallowing and to identify an
overlapping, albeit different, network supporting pharyngeal swallowing. Our findings will provide a theoretical
foundation of swallowing control and contribute to a comprehensive explanatory neuroanatomical model of
dysphagia. In the short term, our findings can improve estimations of dysphagia risks and patient counseling in
the early stroke stages. In the long term, our findings will aid in identifying neuroanatomical targets for
interventions and potentially prevent life-threatening complications associated with dysphagia.

Public health relevance
PROJECT NARRATIVE Dysphagia, or swallowing disorders, affects up to 78% of stroke survivors and can lead to severe consequences, including malnutrition, dehydration, and aspiration pneumonia. However, we lack a comprehensive understanding of the neural mechanisms underlying the swallowing process, hindering our ability to predict patient outcomes and develop effective interventions accurately. Our study addresses this issue by identifying the brain regions that support the oral and pharyngeal phases of swallowing, which could ultimately improve our ability to develop targeted interventions and enhance patient outcomes.